Neocortical and Hippocampal Circuit Dysfunction in the KCNT1 Model of Epilepsy

Variants of the KCNT1 gene encoding the Na+ activated K+ channel results in intellectual disability and a range
of developmental seizure disorders including epilepsy of infancy with migrating focal seizures and sleep-related
hypermotor epilepsy. Prior in vitro electrophysiology in the KCNT1 knock-in variant mouse model showed that
hypoexcitability of a non-fast spiking interneuron subtype in the frontal lobe was the likely cause of local seizure
induction during Non-REM sleep, and contextual fear learning deficits. The extent to which the KCNT1 variant
modifies circuit activity in limbic and frontal regions, and whether these changes result from interneuronopathy
of somatostatin (SST+) or parvalbumin positive (PV+) cells, remain fundamental questions in this model. We
therefore propose simultaneous high-density electrophysiological characterization and optogenetic testing of
activity in dentate gyrus SST+ and PV+ interneuron subtypes. This approach provides unprecedented detail of
the relationship between cell and circuit function in control and KCNT1 mice. Preliminary KCNT1 data show
hypersynchronous hippocampal IEDs and significantly larger dentate spikes, suggesting alteration of the
microcircuitry governing entorhinal-hippocampal pathways. We hypothesize that: A) Hypersynchronous
oscillations the KCNT1 hippocampus result from failure of local SST+ interneuron inhibition and loss of regional
circuit regulation; and B) Selective stimulation of SST+ interneurons, more so than PV+ interneurons, will rectify
inhibitory function and attenuate inter-ictal epileptiform discharges (IEDs). These experiments could establish a
necessary causal link between gene-induced interneuronopathy, cell function and circuit susceptibility to
hyperexcitation and a novel approach for rescuing inhibitory regulation. We will also study the long-term effects
of chronic cell-type selective stimulation on seizure and cognitive outcomes through long-term video and EEG
monitoring and performance on the active avoidance behavioral task.

Public health relevance
Mutation of the KCNT1 gene encoding for Slack channels is associated with multiple pediatric epilepsies and intellectual impairment. The proposed project will test the hypothesis that hypoexcitability of somatostatin positive interneurons, and ensuing disinhibition of a key corticohippocampal neural circuit, is the primary cause of disease related focal and generalized hypersynchrony. We will also test the hypothesis that optogenetically driving the activity of these interneurons at frequencies they can sustain, despite having slack channel mutations, could rectify circuit hypersynchrony in this novel model of developmental epileptic encephalopathy.